Programs for generating inhibitory interneuron diversity and connectivity

SUMMARY:
Inhibitory interneurons comprise a diverse class of neurons of indisputably high biomedical importance.
Interneuron dysfunctions are linked to neuropsychiatric disorders such as autism and schizophrenia and are also
implicated in epilepsy and neurodegeneration. Cortical interneurons are born in the ganglionic eminences. As
they develop, they migrate to intercalate into diverse cortical circuits throughout the brain, where they become
increasingly specialized and modulate many aspects of neural circuit function. Recent transcriptomic and lineage
tracing studies have begun to identify new levels of transcriptional diversity among interneuron subtypes and
between species. Similarly, genomic studies are increasingly identifying genetic risks for disease that are
predicted to impact interneuron function. What is needed to integrate these findings are 1) means to define the
genetic programs that endow interneurons with their successive levels of functional specialization and 2) to be
able to produce these features in vitro for use in disease modeling and genetic loss and gain-of-function studies.
The overall goal of this study is to leverage a new combinatorial transcription factor (TF) screening method for
direct neuronal reprogramming to define transcriptional programs that produce both generic and more
specialized interneuron subtype identities. We will then test the resulting induced interneurons using deep
quantitative methods for cell type phenotyping at the transcriptional, epigenetic, and functional level. We will
apply new AI-enabled in vitro methods to assess cell morphology, motility, and synaptic specificity in vitro, paired
with in vivo assays for migration and specific synapse formation. These collaborative interdisciplinary studies will
accomplish three goals relevant to brain development and repair. First, they will enable the production of defined
interneuron subpopulations in vitro, which will accelerate genetic studies using loss and gain-of-function. Second,
we posit that by performing a high throughput screen for transcription factor “codes” that can induce different
aspects of interneuron diversity, we will uncover new transcriptional modules that govern key functional aspects
of interneuron identity. Third, by developing the first reliable assays to assess the capacity of “synthetic” induced
neuron to achieve synaptic specificity in vitro and in the brain, we will advance reprogramming technology and
open the door to modeling disease that impact some synapses but not others, as is the case for most common
diseases including autism, schizophrenia and Alzheimer's disease.

Public health relevance
TITLE: Programs for generating inhibitory interneuron diversity and connectivity NARRATIVE: Inhibitory interneurons modulate the output of diverse neural circuits, and their dysfunction is linked to a growing number of neuropsychiatric and neurodegenerative disorders. Here we propose to define key functionally relevant programs for producing interneurons and test their functional capacity using deep phenotyping. This will enable new means to identify and implement inhibitory neuron-based therapeutics.